Modernization of the Clinical and Translational Research Vivarium Environmental Monitoring System

PROJECT SUMMARY/ABSTRACT
The University of Louisville (UofL) is an Institution of Emerging Excellence (IEE) and one of 23
states designated by the National Institutes of Health (NIH) as an Institutional Development
Award (IDeA) state, serving the research needs of medically underserved communities. As part
of the IDeA state program, UofL is the recipient of four NIH funded Centers of Biomedical
Research Excellence (COBRE) projects to target local and regional health crises in Kentucky
and Appalachia. These include centers in 1) Center for Cardiometabolic Science, 2)
Microbiomics and Inflammation, 3) Hepatobiology and Toxicology, and 4) Cancer Immunology
and Immunotherapy. UofL is requesting $345,933 for an Avidity Watchdog EX Environmental
Monitoring and Light Control System for the Clinical and Translational Research Building
vivarium (CTRV). The CTRV houses animals for 3 of the 4 UofL COBRE projects’, including the
state’s only Germ-Free/Gnotobiotic Mouse Facility, the university’s rodent imaging core, and
animals utilized by 64 investigators in 16 departments. The CTR vivarium is the largest
vivarium on campus with capacity of >12,000 mouse cages. The new environmental monitoring
system will allow for enhanced monitoring of the vivarium utilized for a diverse range of research
subjects and species including mice, rats, hamsters, and zebrafish. The innovation of the Avidity
Environmental Monitoring and Light Control System will allow real-time monitoring and will issue
remote alarms for all vivarium housing rooms to several veterinary and facility staff allowing for
timely management environmental problems, which will advance operations, minimize research
disruption and strengthen the integrity of the research by reducing variables. The current
Siemens monitoring system is unreliable and has the limitation of only notifying one critical
alarm at a time. In addition, the Avidity system can be connected to the Avidity automated
watering system and detect leaks to the cage rack level with remote alarms to alert veterinary
and facility staff of leaks in the watering system, preventing adverse flooding of animal cages.
Our current system (Siemens) cannot detect water leaks and to our knowledge, the Avidity
system is the only system capable of doing so. We installed the Avidity environmental
monitoring system (including Avidity autowatering) in our newest vivarium and our long-term
objective is to install this monitoring system and Avidity autowatering in all our vivaria (including
CTRV) in the future to assure enhanced animal welfare and reduce environmental variability of
research data. A broad, diverse range of investigators and their research efforts in both
biomedical and basic sciences will benefit from this equipment in this shared-use facility.

Public health relevance
Narrative The University of Louisville (UofL), an Institution of Emerging Excellence (IEE) located in an Institutional Development Award (IDeA) program state, requests funds ($345,933.00) to modernize our 35,373 net sq. ft. shared-use Clinical Translational Research Building (CTR) Animal Facility, which provides animal housing and research support space for rodent and aquatic animal species utilized to advance human health by NIH-funded investigators from 16 departments on the Health Sciences Campus. This modernization includes installation of an Avidity Watchdog EX Environmental and Lighting Monitoring system which will monitor and control temperature and lighting variables which are critical to control in animal experiments for animal welfare and valid, robust research data. The human health research areas studied with animals housed in the CTR include hepatology, immunology, oncology, alcoholism, embryology, neurology, infectious diseases, pharmacology, diagnostic radiology, gastroenterology, and others.